Single-cell multi-omics of cerebellar dysregulation in schizophrenia and bipolar disorder

Project Summary
Neuropsychiatric disorders such as schizophrenia (SCZ) and bipolar disorder (BD) represent a substantial public
health burden. The identification of disease-associated genes and gene networks has long been viewed as one
of the most promising paths toward new therapies. In recent years, substantial progress has been made toward
the discovery of these disease-associated genes through transcriptomic and epigenomic studies of post-mortem
brain tissue. However, while SCZ and BD are associated with structural and functional changes in multiple
cortical and sub-cortical brain regions, large-scale genomic studies have focused almost exclusively on a small
number of neocortical areas. Several lines of evidence support an important role for the cerebellum in SCZ and
BD, including results from brain imaging studies, anatomical studies, and gene expression profiling, and studies
in animal models confirm important roles for the cerebellum in the regulation of emotional states and cognition.
Here, we will perform single-nucleus RNA sequencing and single-nucleus chromatin accessibility assays to
characterize associations of SCZ and BD with cell type-specific transcriptomic and epigenomic changes in the
cerebellum (n=25 each for SCZ, BD, and non-diseased controls). Using these data, we will perform systems
genetics analyses to predict “convergent neuroscience” mechanisms in the cerebellum, linking SNPs to genes
to cell types to brain structure and function to psychiatric diagnoses.

Public health relevance
Project Narrative We will perform single-nucleus RNA sequencing and single-nucleus chromatin accessibility assays to characterize cell type-specific transcriptional dysregulation in the cerebellum of individuals with schizophrenia and bipolar disorder.